Acquisition of a Fast Shuttle System Apparatus

Funding is requested to obtain a Bruker Biospin Fast Shuttle System (FSS) Apparatus to be installed
on an existing 700 MHz NMR spectrometer at the New York Structural Biology Center (NYSBC), a
consortium of nine research institutions in New York State. The requested instrumentation is essential
to the over-riding purpose of NYSBC and its NIH-funded RM-1 Center for Macromolecular Dynamics
by NMR Spectroscopy (CoMD/NMR) to support the specific aims of the NIH-funded research of the
major and minor users of the requested instrumentation. The FSS Apparatus is a technological
breakthrough that enables for the very first time measurements of spin-lattice relaxation rate
constants for 1H, 15N, 13C and other spins in biological macromolecules, including proteins and nucleic
acids over the full range of magnetic fields from 100 µT to 16.4 T (termed R1 relaxation dispersion or
relaxometry) The FSS Apparatus consists of a fast shuttle system, a magnetic tunnel inserted into the
bore of the NMR dewar, and an external electromagnet field cycling coil (FCC) mounted on top of the
NMR magnet dewar. The key part of the FSS Apparatus is the magnetic tunnel, which maintains the
minimum field in the bore of the magnet >1 T in order to prevent extremely large increases in R1
during transfer from high field (in the superconducting coil) to low field (in the FCC) and back.
Consequently, sensitivity is dramatically increased, relaxation effects during shuttling of the sample
are minimized, and lower magnetic fields can be accessed, compared to existing shuttle systems
lacking a magnetic tunnel or FCC (relying only on the fringe field of the superconducting coil). The
FCC is designed to operate in the range 100 µT to 0.8 T, while the fringe field of the spectrometer is
used to measure relaxation rates at fields > 0.8 T. Both theoretical calculations and preliminary
measurements of 15N and 13C R1 relaxation dispersion demonstrate that conformational dynamics of
biological macromolecules can be characterized in unprecedented detail using the FSS, compared
with high-field measurements (>10 T) or relaxometry using only the fringe field (>0.5 T). The
requested FSS Apparatus will be the third one in the world and first in the United States; thus, a key
goal of CoMD/NMR is to make this groundbreaking technology available to the major and minor
users, but also to the national research community. The research conducted using this transformative
technology ranges from fundamental studies of structure/dynamics/function of biomolecules, to
elucidation of mechanisms of pathogenesis, to discovery of novel lead compounds, and to
pharmaceutical applications.

Public health relevance
Narrative The New York Structural Biology Center (NYSBC), a consortium of nine research institutions in New York State, houses and supports ultra-high field (>600 MHz) NMR spectrometers and associated instrumentation used by scientists both at its member institutions and nationally, through the NIH- funded Center on Macromolecular Dynamics by NMR Spectroscopy. The requested Fast Shuttle System Apparatus will be installed on an existing 700 MHz NMR magnet system at NYSBC. The new instrumentation is a breakthrough for the study of dynamics of biological molecules and will enable research ranging from understanding fundamental biological processes in normal and pathological states to discovery of potential new drugs for treatment of cancer and other diseases.